PheWAS and GWAS of Telomere Length to Understand Human Disease

ABSTRACT:
Human diseases are influenced by complex interactions between genetic and environmental factors.
Identifying genomic biomarkers that can transcend these complexities would be of great importance.
Telomeres are repetitive DNA sequences that cap the ends of chromosomes. They are necessary for
maintaining chromosomal stability and play an important role in cell viability. As humans age, telomeres
become shorter with every cellular division thus providing the cell with an internal biological clock for
viability. When telomeres become excessively short, the cell enters replicative senescence.
Dysregulation of telomeres is common in many cancers, and variability in telomere length (TL) is known
to be associated with many diseases. Genome-wide association studies (GWASs) have also identified
approximately 30 candidate variants that influence normal variation in TL, and some of these variants
have been linked to human disease. It is hypothesized that TL, and variants that are associated with
TL, may provide diagnostic and predictive information for many diseases. To test this hypothesis, we
propose the following aims: (1) associate thousands of clinically significant phenotypes with TL by
phenome-wide association studies (PheWAS), (2) conduct the largest single GWAS of TL to identify
novel variants associated with the trait, and (3) identify diseases that are associated with genetic
variants that influence TL by PheWAS. To accomplish these aims, this study will leverage 70,000
ethnically diverse DNA samples from two large healthcare systems. All DNA samples are linked to
genomic data and long-term electronic health records. Through the proposed GWAS and PheWAS
experiments, we expect to gain knowledge concerning the importance of telomere biology in human
health and its diagnostic utility for various diseases.

Public health relevance
Title: PHEWAS AND GWAS OF TELOMERE LENGTH TO UNDERSTAND HUMAN DISEASE PROJECT NARRATIVE: Telomeres are variable length DNA caps that protect our chromosomes and play an important role in human disease processes. Normal variation in telomere length has been linked to genetic and environmental factors. Using extensive genomic information in Marshfield Clinic's and Vanderbilt's DNA biobanks linked to an extensive electronic health record, this study will conduct phenome- and genome- wide association studies to comprehensively evaluate the role of telomere biology in human health.